Specificity of regulatory T cell suppression during infection

ABSTRACT
A fundamental question in immunology lies in understanding how the immune system can mount robust T cell
responses to foreign pathogens, while restricting collateral damage to endogenous tissues, a state often
referred to as "self vs. non-self discrimination". Although many self-reactive conventional T (Tconv) cells are
removed from the body by clonal deletion, considerable evidence demonstrates that this process is imperfect.
The control of remaining self-reactive Tconv cells requires suppression by CD4+Foxp3+ regulatory T (Treg)
cells, which function throughout life to prevent autoimmunity. Efforts to define the mechanisms by which Treg
cells suppress Tconv cells have revealed numerous potential mechanisms, including the masking of co-
stimulatory ligands, the local production of suppressive cytokines, or the hoarding of key accessory factors.
However, these antigen non-specific "bystander" mechanisms are not sufficient to explain self vs. non-self
discrimination, especially in the context of innate immune activation during infection, highlighting the
importance of new research examining the mechanisms of Treg-mediated suppression. Previously, we
identified two self-peptides ("C4" and "F1" peptides) that are recognized by naturally occurring Treg cell
populations and are derived from a single prostate-specific protein, Tcaf3. Here, we demonstrate that selection
on the C4 peptide during repertoire formation is critical for the prevention of prostatitis, and that polyclonal Treg
cells of other specificities can not compensate for the shift in the C4-specific T cell pool. This reveals a key role
for Treg-mediated suppression of Tconv cells of matched peptide/MHC-II (pMHC-II) specificity, as opposed to
broad antigen non-specific mechanisms. The objectives of this application are to elucidate mechanisms by
which Treg cells coordinate pMHC-II-specific immune suppression at steady state and during infection. We will
achieve our objectives in close collaboration with Dr. Ron Germain, an expert in advanced imaging techniques,
and Dr. Nancy Freitag, an expert in the genetics of the bacterium Listeria monocytogenes (Lm). In Aim 1, we
will use functional experiments and advanced confocal imaging to define the mechanistic basis of pMHC-II-
specific Treg cell suppression at steady state, testing the hypothesis Treg cells do not prevent the initial
activation of pMHC-II-matched Tconv cells, but instead rheostatically respond to activated Tconv cells to
restrict their subsequent differentiation and expansion. In Aim 2, we will define the role of Treg cell pMHC-II
specificity in coordinating self vs. non-self discrimination during Lm infection, testing the hypothesis that robust
pMHC-II-specific suppression by self-selected Treg cells is imparted by both quantitative (numerical)
advantages and qualitative properties induced by the recognition of peripheral self-ligand prior to infection. In
all, our work is expected to elucidate key mechanisms by which the immune system orchestrates host defense
while limiting collateral damage to self tissues.

Public health relevance
PROJECT NARRATIVE: A fundamental question in immunology lies in understanding how the immune system can mount robust protective responses to foreign pathogens, while restricting collateral damage to endogenous tissues. Here, we will define the role of Foxp3-expressing regulatory T cells in coordinating this process, and elucidate the mechanisms by which Treg cells are able to suppress the activation of conventional T cells reactive to the same antigenic complex. In all, our work is expected to providing key insight into how the immune system prevents autoimmunity during pathogen infection, which has direct implications for the understanding of autoimmune disorders and inflammatory syndromes.